Sphingolipids in Cancer Biology and Therapy

ABSTRACT
The overall organizing hypothesis of this Program posits that the highly integrated sphingolipid (SL)
metabolism regulates important cancer functions, especially in anchorage-independent growth (AIG), DNA
damage response, and cytotoxic responses. As a consequence, enzymes of SL metabolism are emerging as
clear targets for specific intervention as well as for modulation of adverse effects of chemotherapeutics.
Unfortunately, the study of bioactive lipids encounters significant complexities, both conceptual and technical
and thus the study of lipids necessitates the collaborative interactions of various disciplines and specialized
cores. Thus, we have evolved 3 distinct projects that collaborate to investigate the overall hypothesis, focusing
on breast cancer. These projects address highly interrelated metabolic pathways with important functions. Each
project has identified a key node in these pathways that constitutes a specific vulnerability in the target cancer
under study. Thus, Project 1 will test the hypothesis that neutral sphingomyelinase 2 is an important tumor
suppressor enzyme, acting through ceramide and downstream signaling pathways to prevent the progression
and metastasis of breast cancer. Project 2 will test the hypothesis that the p53-dependent upregulation of
ACER2 mediates chemotherapy-induced myelosuppression. Clinically, inhibiting the ACER2/SPH pathway
should mitigate CIM and thereby improve the efficacy of chemotherapy against p53-mutant cancers. Project 3
will test the hypothesis that targeting critical nodes of SL metabolism to mimic the SL response observed with
cytotoxic chemotherapy doses will sensitize BC cells to low doses, while also overcoming dangerous
prometastatic functions. These 3 projects will be supported by two unique research cores: The Lipidomics
Shared Resource which will provide advanced analytical lipid chemistry with new and novel capabilities for flux
analysis and tissue imaging of lipids, and by a Sphingolipid Animal Cancer Pathobiology Shared Resource
that focuses on mutants/knock outs in enzymes of sphingolipid metabolism and models of in vivo carcinogenesis.
It has recently introduced biobanking and CRISPR-mediated nock outs. This Program group has been highly
integrated and productive (having published in the past 5 years 80 manuscripts, 45 of which were in
collaboration) and has advanced significantly our understanding of sphingolipids (one of the last frontiers of basic
research) in caner biology and therapeutics. We are now poised to advance pre-clinical studies and translational
research based on our understanding of these novel pathways. These studies continue to identify novel targets
and strategies for cancer therapeutics.

Public health relevance
PROJECT NARRATIVE This program project aims at defining how specific pathways of lipid (fat) metabolism and specific enzymes in these pathways regulate key functions of cancer (regulation of cancer growth, invasion, differentiation, and metastasis), focusing on breast cancer. Determining these novel pathways and mechanisms not only enhances our understanding of cancer behavior, but also promises to lead to the identification of novel targets for developing new inhibitors of cancer by focusing on specific enzymes (ceramide kinase, alkaline ceramidase, sphingosine kinase, and sphingomyelin synthase). The study of sphingolipids is very difficult and highly specialized, yet very promising for cancer research, and our program brings together several investigators with complementary and overlapping interests and expertise, and we have also developed two unique shared resources: an Animal caner pathology core and a lipidomics core, which are unique in their operations and services.